High-throughput functional analysis and clinical relevance of all possible variants of a gene

Modern pharmaceuticals have greatly improved the quality of life for many patients suffering a variety of illnesses.
Unfortunately, among the 17 most commonly prescribed drugs, only 6 are highly effective for most patients, 5
have a modest effect, and 6 show little clinical effect. Worse still, unwanted illness and death from treatment of
patients with the incorrect drug or dosage causes over 275,000 unnecessary deaths annually in the United
States, making it the 3rd-leading cause of death.
Genomic screening can minimize the loss of lives by clearly defining the cause-and-effect between a patient’s
genetic sequence and their disease. Many gene sequences are known to affect a person’s response to drugs.
The FDA lists over 450 warnings or recommendations for drug use based on possible genetic variants in specific
genes. Other public databases list ~60,000 “characterized” gene variants, but their importance is often unknown.
Moreover, these variants represent a vanishingly small fraction of >900 million known human genetic variations.
The vast number of “Variants of Uncertain Significance” (VUS) present potentially life-altering medical, ethical,
legal, and societal complications. Some cause drugs to be more or less effective in different patients. Others can
stimulate growth of cancer cells or make those cells resistant to chemotherapies.
To understand the biological impact of gene variants, Heligenics has developed the GigaAssay™ technology to
measure the functional effect of all variations within any selected gene. In contrast to similar technologies, the
GigaAssay reports the activity of each variant of the gene, with high accuracy and reproducibility.
In this proposal, we plan to improve the GigaAssay and show its feasibility for detection and analysis of gene
variants that have clinical importance. In Aim 1 we will create a battery of GigaAssay cell lines and readouts for
rapid analysis of several functional cellular activities. In Aim 2 we will demonstrate that the GigaAssay can detect
gene variants that cause resistance to an FDA-approved chemotherapy drug.
This work will directly address numerous goals of the “Illuminating the Druggable Genome” project of the NIH.
Future plans include expanding the number of GigaAssays, increasing the speed or number of genes that can
be studied, and partnering with drug developers and clinical trial managers to identify the optimal drug for each
patient, based on his or her genetic variants.

Public health relevance
Genomic sequencing can identify SNPs to diagnose disease, predict prognosis, and maximize drug efficacy, but the effect of >99% of SNPs remains unknown. To discover the effect of gene variants, we have developed the GigaAssay to analyze the function of every possible single-amino-acid substitution in a high- throughput format. In this proposal we will build a library of GigaAssays to analyze most drugs and genes of interest, and then test the feasibility of the GigaAssay to identify drug-resistance mutations.